ACTG 245--COMBINATION ANTIRETROVIRAL THERAPY IN ADVANCED HIV DISEASE

Three treatment regimens will be studied to determine whether combination antiretroviral therapy can durably reduce viral load and prevent the emergence of multidrug viral resistance. This study also will assess whether viral parameters can be correlated with clinical disease progression. The study has closed to subject follow-up. Data analysis is underway.